Deep in the Heart for Women: A Community-Engaged Intervention Study to Catalyze a Culture of Health in Rural South Texas

PROJECT SUMMARY
Cardiovascular disease and obesity are conditions that cause high morbidity in women, including women in
rural areas; contextually tailored, evidence-based multilevel, multicomponent interventions that take social
determinants of health into account are needed to prevent or improve risk factors for obesity and
cardiovascular disease (e.g., dietary patterns, physical activity behaviors). The proposed project, Deep in the
Heart, includes the following specific aims: 1) facilitate local community engagement and conduct formative
research to inform tailoring for the intervention components as well as engagement and implementation
strategies based upon data from bilingual focus groups with diverse residents and input gathered from a local
Community-Clinical Advisory Board and a National Rural Advisory Board; 2) evaluate the Deep in the Heart
intervention (experiential obesity and cardiovascular disease prevention group classes including aerobic
exercise, strength training, and dietary skill-building facilitated by a Community Health Worker, with participant
referral to resources based on social determinants of health survey; mobile health app for goal setting and self-
monitoring; and a Community-Clinical Advisory Board refining and promoting a local Community-Clinical
Resource Guide) in a community-engaged study in a diverse, medically underserved rural county in south
Texas (>80% Hispanic); 3) conduct implementation and process evaluation guided by RE-AIM and the
Consolidated Framework for Intervention Research; and 4) conduct cost-effectiveness analysis to inform
resource allocation for future scalability. Deep in the Heart holds great potential to meaningfully reduce obesity
and cardiovascular disease risk, improve rural women’s health equity, and provide an effective shorter-duration
program, which will allow participation by individuals who may not enroll in a longer program due to scheduling,
transportation, caretaking, or other constraints.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) and obesity are conditions that cause high morbidity in women, including women in rural areas; contextually tailored, evidence-based multilevel interventions that take social determinants of health into account are needed to prevent or improve risk factors for obesity and CVD (e.g., dietary patterns, physical activity behaviors). The proposed intervention, Deep in the Heart, includes the following objectives: 1) facilitate local community engagement and conduct formative research to inform tailoring for the intervention components as well as engagement and implementation strategies based upon data from bilingual focus groups with diverse residents and input gathered from a local Community-Clinical Advisory Board and a National Rural Advisory Board; 2) evaluate the intervention (consolidated from 24 to 12 weeks, experiential obesity and CVD prevention classes facilitated by a Community Health Worker, mobile health app, and Community-Clinical Resource Guide) with women in a community-engaged study in a diverse, medically underserved rural county in south Texas (>80% Hispanic); 3) conduct implementation and process evaluation via interviews, focus groups, and questionnaires; and 4) conduct cost-effectiveness analysis. Deep in the Heart holds great potential to meaningfully reduce obesity and CVD risk, improve rural women’s health equity, and provide an effective shorter-duration program, which will allow participation by individuals who may not enroll in a longer program due to scheduling, transportation, caretaking, or other constraints.